EXPERIMENTAL THERAPEUTIC TRIAL OF THE ANTIOXIDANT IDEBENONE IN HUMTINGTON'S DIS

This study compared the safety and efficacy of idebenone (Avan) and placebo in treating the cognitive, motor and affective disorders associated with Huntington's Disease (HD).